A sleep intervention to improve quality of life and symptom management in Veterans with the polytrauma clinical triad

The co-existence of traumatic brain injury, post-traumatic stress disorder (PTSD), and chronic pain defines the
clinical entity referred to as the “polytrauma clinical triad” (PCT). Well recognized to be highly prevalent and
disabling in US military service members and Veterans, those with the PCT are traditionally viewed as the
most disabled cases and most refractory to conventional therapies. Central to the challenge in effectively
treating Veterans with the PCT is the bi-directional, mutually reinforcing relationship between these conditions.
Further complicating is the influence of sleep and cognitive impairment, both of which are widely regarded as
primary contributing chronic sequela associated with the PCT. The specific contribution from sleep in
exacerbating this clinical picture is supported by extensive scientific precedent demonstrating impairments in
sleep intensify and worsen these related sequela (e.g., cognitive impairment, pain management, and PTSD
symptom severity), which in turn, contribute to further impairment in sleep. Accordingly, an effective
intervention targeting sleep may alleviate rehabilitative pressure on these associated sequelae and facilitate
breaking out of this vicious cycle (i.e., poor sleep exacerbating outcomes, and in turn, further impairing sleep).
Recent work from our laboratory and preliminary data from a current VA RR&D CDA-2 (PI: Dr. Elliott;
Research Physiologist at the Portland VA) demonstrate promise for a simple, at home, non-pharmacologic
and cost-effective, sleep focused intervention: morning bright light therapy (MBLT). We have demonstrated
robust feasibility, acceptability, and limited efficacy for MBLT to improve sleep, and thereby, improve cognitive
function, PCT symptom management and overall quality of life in this medically complex and vulnerable
population. Accordingly, this proposal aims to extend the foundational work from the CDA-2 to inform a
prospective phase II placebo-controlled randomized clinical trial examining effectiveness for MBLT as a sleep-
based intervention in Veterans with the PCT.
Specific aims designed to test this hypothesis are to determine effectiveness for MBLT to improve 1) sleep, 2)
cognition, and 3) PCT symptom management in Veterans with the PCT. We propose to enroll n=138 Veterans,
randomized 2:1 to MBLT (10,000 lux light exposure for 60 min within 120 min of waking for 4-weeks) or a no-
light sham-MBLT condition (as previously published using the same duration/timing). Sleep, cognition and PCT
symptom management will be assessed through a novel combination of subjective/self-report, objective
measures, and ecological momentary assessment sampling. Specific objective assessments include wrist-
based actigraphy and as exploratory outcome in a sub-set of participants, home-based overnight
polysomnography. Outcomes will be assessed pre- and post-intervention, with follow-up at 6- and 12-weeks
post-intervention.
It is expected the proposed work will demonstrate effectiveness for MBLT to improve sleep, cognition, and PCT
symptom management including ameliorating chronic pain and improving quality of life, in Veterans with the
PCT. This project will demonstrate, 1) an effective treatment option, alone or in combination with existing
rehabilitative efforts, in Veterans with the PCT, and 2) sleep-wake disturbances may be implicated in the
pathogenesis of these functional impairments, thereby establishing greater precedent for targeting sleep as a
meaningful primary and/or adjunctive rehabilitative therapy.

Public health relevance
The “polytrauma clinical triad” (PCT), a highly disabling constellation of factors, is defined by the coexistence of traumatic brain injury, post-traumatic stress disorder, and chronic pain. Veterans with the PCT are medically complex, often refractory to conventional therapies, and suffer from additional related chronic sequela. Notably, sleep disturbances and cognitive impairment, which we hypothesize are significant contributing factors to these functional impairments and an impediment toward rehabilitation. Thus, our research aims to intervene “at the level of sleep”, and by improving sleep, improve these interconnected, disabling, and difficult to treat enduring complexities associated with the PCT – ultimately to improve Veteran quality of life, functional independence, and restorative function. We predict that the proposed intervention, morning bright light therapy, which is cost- effective, rapidly deployable and home-based, will be effective in improving sleep and overall PCT symptom management, thereby, resulting in a measurable and impactful improvement in quality of life.